Translational Research in AD and related Dementias (TRADD)

Abstract
The University of Arizona (UA) Training Program to Advance Translational Research on Alzheimer's Disease
and AD Related Dementias is designed to address knowledge and experience gaps in AD therapeutic
discovery and preclinical translational development. To meet this challenge, the UA Translational Research in
AD and related Dementias (TRADD) training program is designed as a problem based translational learning
experience for predoctoral Ph.D and M.D. Ph.D fellows. In alignment with the 2012, 2015 and 2018 NIH
Alzheimer’s Disease Research summits and the National Alzheimer’s Project Act, the goal of the TRADD
training program is to fill critical gaps that exist for AD translational research in academic graduate programs.
To achieve this goal, the University of Arizona TRADD program will: 1) recruit trainees across multiple scientific
disciplines; 2) employ problem-based learning approaches to solve challenges in AD therapeutic development
with emerging tools and techniques; and 3) equip TRADD trainees with career development and leadership
skills necessary to conduct team science and manage multidisciplinary teams in the 21st century. Through this
approach, we ensure that TRADD trainees develop deep translational research expertise necessary for AD
therapeutic development, while: 1) cultivating the ability to creatively and collaboratively solve problems
working with experts across the translational landscape as part of large-scale team science; 2) gaining an
applied understanding of how data science, particularly using data generated by AMP-AD, M2OVE-AD and
ADNI, can accelerate translational research and provide avenues to novel therapeutic insights; 3) connecting
geno- and phenotypic variations and multifaceted etiology of AD to therapeutic targets; and 4) gaining essential
professional and business skills to navigate a diverse funding landscape and translate discoveries into the
clinical setting. TRADD fellows will receive career mentoring and leadership development skills to manage
multi-disciplinary teams in the 21st century that is Patient Inspired and Data Driven. The UA TRADD training
program will develop a diverse, cross-disciplinary and translationally oriented workforce to meet the critical
challenge of creating a workforce capable of advancing therapeutics to prevent, delay and treat AD and AD
related dementias.

Public health relevance
Project Narrative The University of Arizona Training Program to Advance Translational Research on Alzheimer's Disease and AD Related Dementias is designed to create a workforce capable of developing therapeutics to address the national and global crisis of Alzheimer’s disease.